The dynamics, functions and evolution of a miniature RNA-guided enzyme

Project Summary/Abstract
The goal of this proposal is to dissect the dynamics, functions, and evolution of TnpB, a transposon-encoded
RNA-guided endonuclease, to enhance its genome-editing efficiency and expand its functions beyond DNA
cleavage. While RNA-guided enzymes like CRISPR-Cas9 and Cas12 have revolutionized programmable
genome engineering, there is a growing demand for smaller and more versatile enzymes. With its compact
size (~400 amino acids), TnpB is well-suited for delivery systems with strict cargo limits, such as adeno-
associated viruses (AAV). Moreover, its greater abundance and evolutionary diversity present opportunities to
develop new RNA-guided tools with broader applications.
However, key aspects of TnpB’s mechanism remain unclear, limiting its potential. Specifically, three
major knowledge gaps need to be addressed: (1) What molecular determinants drive TnpB’s editing efficiency,
and how can they guide the engineering of more efficient variants? (2) How do TnpB and reRNA, its guide
RNA, co-evolve, and can this knowledge be used to design novel protein-RNA complexes? (3) How is mature
reRNA generated, and can this knowledge inform the design of RNA motifs with improved processing
efficiency? This proposal will address these questions through three specific aims: Aim 1 will develop a
quantitative kinetic model for TnpB’s targeting efficiency to determine rate-limiting steps, using biochemical and
single-molecule biophysical measurements. Aim 2 will explore the co-evolution between TnpB and reRNA,
through bioinformatics, structural biology, and functional assays, to understand how their 3D structures have
adapted together and to identify key hotspots for structural changes. Aim 3 will investigate the reRNA
maturation pathway using RNA biochemistry and structural probing, focusing on how reRNA is processed into
a functional guide RNA, and seek to design RNA motifs for more efficient reRNA processing.
In the K99 mentored phase mentored by Dr. Jennifer Doudna, I will receive hands-on training in single-
molecule biophysics (rotor bead tracking) with Dr. Zev Bryant (Stanford) to complete Aim 1, while also gaining
expertise in bioinformatics for evolutionary analysis and structural biology techniques (cryo-EM, RNA structural
probing) in preparation for Aims 2 and 3. Additionally, I will focus on developing essential professional skills for
my independent career, such as lab management, mentorship and networking. This comprehensive scientific
and professional training in the K99 phase will prepare me for the R00 independent phase, where I will lead the
completion of Aims 2 and 3 and establish my own research laboratory. These combined efforts will provide
more quantitative and detailed mechanistic insights into TnpB’s function and evolution, enabling the
development of future RNA-guided genome-editing tools combining compact sizes, robust activities, and
expanded capabilities for both research and therapeutic applications.

Public health relevance
Project narratives This proposal aims to unravel the molecular mechanisms governing TnpB, a compact RNA-guided endonuclease, with the goal of improving its efficiency as a genome-editing tool and unlocking new functionality beyond DNA cleavage. By integrating biochemical analysis, single-molecule biophysics, structural biology, and bioinformatics, this project will develop a more quantitative and comprehensive understanding of TnpB’s targeting efficiency, its co-evolution with guide RNA, and the guide RNA processing pathways involved. If successful, this work will lead to the development of next-generation RNA-guided systems with small sizes, enhanced genome editing behaviors, and versatile functions beyond DNA cleavage, with broader applications in therapeutic and research contexts.